Tackling Treg mediated resistance to radiation and anti-PDL1 in HNSCC's

ABSTRACT
We have shown that elective nodal irradiation (ENI) blunts systemic immunity in preclinical models of head and
neck cancer (HNC), but without it, the risk of regional recurrence in the lymph nodes (LN) is high. Data from
clinical trials showed that omission of ENI is feasible, but nodal progression or recurrence does vary by the
choice of immunotherapy (IO) that is combined with the radiation (RT). Our previous trial showed that
combination aPDL1 (Durvalumab) with tumor-only RT resulted in exceptional high pathological and clinical
response rates and no nodal recurrences. However, in two other separate trials, when either another a-
PDL1(Atezolizumab) or a-CTLA4 was added to Durvalumab-RT, it resulted in high rates of nodal recurrence
leading to trial closures. This suggests that target cell activation or inhibition varies by the type of IO or
combination IO used in the context of RT and dictates nodal outcome. Our preliminary data show that trial
patient progressive nodes contained a high percentage of Tregs and, preclinically, genetic knockout of PD1 on
Tregs increases their activation, which we have previously shown to be driven by STAT3. We demonstrate that
nodal metastasis can be prevented by early depletion of Tregs prior to tumor implantation. This is accompanied
by enhanced morphological maturation of high endothelial venules (HEVs), specialized postcapillary venules
whose function within DLNs has been correlated with immune trafficking and activation. Localized within
perivascular niches, and surrounded by Tregs and cancer cells, these HEVs, which express LTBR, are
decreased in numbers and maturation on nodal recurrence, a phenomenon that is reversed by LTBR agonists.
We also show that ST2 Tregs, a specific Tregs subset, are upregulated with RT and that genetic knockout of
ST2 on Tregs results in marked tumor regression. Recombinant administration of IL33 (ST2's ligand), on the
other hand, combined with RT and Treg depletion, leads to high rates of eradication of nodal recurrence. We
hypothesize that activation of PD1 expressing Tregs in the RT-IO setting contributes to cancer immune
evasion directly via STAT3 pathway activation, indirectly through LTA1B2-LTBR Treg-HEV interaction,
thereby limiting the Teff infiltration into the nodal environment, and through the ST2-IL33 Treg-stromal
interaction, abrogating Teff cells' expansion potential. In Aim1, we will examine the mechanistic impact of
immune check point inhibition on Tregs; in Aim2, we will test how Treg-HEV interaction facilitates a tumor-
promoting environment within the LN, leading to immunosuppression and cancer cell immune evasion; and in
Aim 3, we will determine how ST2 expressing Tregs modulate tumor immune microenvironment in nodal
progression. These will be tested using genetically engineered mouse models, multicompartmental mass
cytometry, scRNA seq, metabolomic and proteomic analysis, and multispectral immunofluorescence preclinically
and in clinical trial specimens from those with and without nodal failure. These studies will collectively elucidate
mechanisms of nodal progression with profound impact for therapeutic discovery.

Public health relevance
NARRATIVE A recent HNSCC clinical trial using radiation and aPDL1 resulted in excellent response rates, but when combined with a different aPDL1 or when another checkpoint blockade was added to RT and aPDL1, the same trial resulted in nodal progression and halting of the latter two trials. Having identified Tregs in our preliminary preclinical and clinical data as key component mediating this phenomenon, we will focus on tackling aspects of Tregs' activation, signaling, fragility, and trafficking, in the hope that it will lead to novel therapeutic approaches that mitigates cancer immune evasion within the draining lymph node.